2023 Annual Meeting of Society for Pelvic Research.

Project Summary:
The Society for Pelvic Research (SPR), founded on May 12, 2015, by and for career basic and translational
scientists interested in normal function and benign disease states of the pelvic viscera and pelvic floor, is
dedicated to cross-disciplinary basic and translational scientific interaction and trainee development. The
society's mission is to promote the highest standards of basic and translational science research directed toward
understanding benign pelvic visceral and musculoskeletal function and dysfunction through education, scientific
discussions, interaction, and advocacy. This includes such conditions as urinary and fecal incontinence, male
and female sexual dysfunction, overactive and underactive bladder syndromes, colonic motility disorders,
urologic chronic pelvic pain syndrome (UCPPS), and pelvic organ prolapse. These disorders are highly
prevalent, especially in our aging populace, and have significant negative impacts on the health, quality of life
and financial well-being of a very large portion of the population. The SPR envisions being the premier
professional organization for career basic and translational scientists and bioengineers interested in benign
urogenital, distal gut and pelvic floor research. It promotes multidisciplinary interaction, intellectual cross-
fertilization, networking for collaboration, and career development through the regular dissemination of
information via online resources, future published guidelines and standards for basic and translational science
research, and, most importantly, through the SPR annual meetings. The Specific Aim of this R13 application is
to partially support the 8th annual meeting of the SPR to be held in Savannah,GA, December 7-9, 2023, with
the . While there are other forums to present research
findings, the SPR is the only society whose stated primary focus is to support the careers of basic and
translational scientists that form the backbone for the discoveries that will eventually be implemented into clinical
practice. At the 2023 meeting, each of the sessions, covering a broad range of topics of interest to current and
potential future members of the SPR, will be unified by the underlying theme of aging. Our invited keynote
speakers for 2023 will cover the influence of aging and age-associated conditions on the bladder, prostate, pelvic
floor, and lower urinary tract function, in presentations entitled: “Aging in the bladder”, “Age-associated changes
Trainee Workshop Session being held on December 7
in prostatic mitochondrial function and development of LUTS and BPH”, “Theinteraction of Aging and other Life
Eventson Pelvic Floor Function”, and “Effects of aging on neuroregulation of the lower urinary tract”. The SPR
is committed to diversity and inclusion, as evidenced by more than 50% of positions on its Board of Directors
(BOD) that are held by women. Our intention for this meeting, as with previous meetings, is to ensure the
participation by underrepresented basic and translational scientists as invited speakers and attendees.

Public health relevance
Project Narrative: The Society for Pelvic Research (SPR), founded on May 12, 2015, by and for career basic and translational scientists interested in normal function and benign disease states of the pelvic viscera and pelvic floor, is dedicated to cross-disciplinary basic and translational scientific interaction and trainee development. The Specific Aim of this R13 application is to partially support the 8th annual meeting of the SPR to be held in Savannah,GA, December 7-9, 2023, with the Trainee Workshop Session being held on December 7 (and to ensure the participation by underrepresented basic and translational scientists). While there are other forums to present research findings, the SPR is the only society whose stated primary focus is to support the careers of basic and translational scientists that form the backbone for the discoveries that will eventually be implemented into clinical practice.